STUDY TO DETERMINE LEVEL OF PHYSICAL CONDITIONING IN PATIENTS WITH SEVERE BURNS

To study the degree of deconditioning and reconditioning that occurs following burn injury and subsequent rehabilitation.